Smart Needle with Intelligent Robotic Control for Prostate Brachytherapy

PROJECT SUMMARY/ABSTRACT
Brachytherapy procedure is one of the most popular treatment modalities for prostate cancer where cancerous cells are
irradiated and destroyed locally by the radioactive dosage of seeds implanted by the surgeon. The success of brachytherapy
heavily relies on safe and precise placement of the seeds in or adjacent to the cancerous cells. The procedure demands a
very experienced surgeon who have developed an intuitive feel in needle insertions and is able to guide the needle into a
desired location with hand-eye coordination and assistance of an imaging device. However, with conventional rigid needles,
only a straight path is achievable towards the target, and thereby seed placements require several insertions with a high
tissue damage on the needle’s path. A recent study has shown that guiding the needle in a curvilinear approach will decrease
the number of needle insertions required and provide other dosimetric benefits. Lack of actuation and control (after the
needle is inserted into the patient’s body) is another factor that make the procedure challenging. A flexible 3D steerable
“smart” needle with multi-directional actuation and a reliable guidance control and guidance can aid the surgeon to perform
the task with more accuracy, reduced invasiveness, and in a curvilinear approach. Furthermore, teleoperative guidance for
the smart needle will endow the robotic instrument with intelligence. On the other hand, in-depth understanding of the
needle-tissue interaction mechanism (with intraoperative model parameter updates and shape- and force-sensing) is a key
factor in development of an appropriate control and guidance strategies to compensate for system uncertainties. This work
will first develop an active “smart” brachytherapy needle that will provide robust actuation, shape- and force-sensing, and
3D motion in tissue. Then a teleoperative interface with robot-driven smart needle will be developed to perform semi-
automated brachytherapy. Realistic analytical and computational models of needle-tissue interactions will be developed
using realistic tissue characteristics. These models will be used in the control system as dynamic models to make appropriate
decisions during an insertion task. The innovative features of our proposed methods rely on our cutting-edge smart needle
design, new dynamic models, shape- and force-sensing, and control algorithm specifically developed for this application.
The present studies will develop a clinically acceptable size “smart” surgical needle with a robotic control interface and
evaluate its impact in brachytherapy procedure. Utilization of active and passive flexible needles for diagnosis and
therapeutic procedures is a rapidly advancing filed. This proposed research has a high potential to lead to a revolutionary
needle insertion practice in healthcare that is also beneficial to various needle-based procedures such as drug delivery,
biopsy, and interventional therapy where an accurate placement is needed with minimal tissue damage.

Public health relevance
PROJECT NARRATIVE This project will develop a “smart” needle for accurate and less invasive radioactive seed implantation in prostate brachytherapy. Analytical and computational models, with model parameter updates, will be developed based on realistic tissue properties to have a better understanding of needle-tissue interaction mechanism. The smart needle will be integrated with a teleoperated user control interface, with better understanding of the dynamics of the system and shape- and force- sensing, to improve needle guidance into a desire path towards the target, and thereby improved clinical outcomes.